The contributions of synaptic ribbons to retinal circuit function and assembly

PROJECT SUMMARY
The retina faces the considerable challenge of continuously and reliably encoding a wide dynamic range of light
intensities. At the first two synapses of the retina are ribbons, large planar structures often described as ‘conveyer
belts’ that continuously supply active zones of release with glutamate vesicles. As such, ribbons are thought to
mediate high rates of glutamate release that allow for dynamic encoding of visual stimuli. In the retina, visual
information flows from photoreceptors to bipolar cells to ganglion cell (GC) output neurons that send information
to the brain in the form of spikes. In mice, there are at least 40 functionally distinct retinal GCs, each tuned to
different features of the light environment and exhibiting unique circuit organizations. Therefore, our
understanding of how the retina informs the brain is based on understanding how ribbons mediate the transfer
of visual information through retinal circuits to shape GC output. The goal of this project is to determine how the
function of two different GCs—ON-sustained and OFF-sustained alpha—are shaped by ribbons.
As lighting conditions change, glutamate release probability at ribbon synapses is dynamically adjusted to match
sensitivity needs—termed light adaptation. However, whether ribbons are directly responsible for regulating
glutamate release during light adaptation is unclear. To answer this question, by measuring synaptic inputs to
ON-sustained and OFF-sustained alpha GCs in a ribbon loss-of-function (Ribeye-ko) mouse model, I will first
determine if ribbons regulate two forms of glutamate release that are thought to be important for adaptation:
multivesicular release (MVR), the simultaneous release of multiple vesicles, and synaptic depression, a transient
reduction in release probability following a stimulus. I will then use more dynamical stimulation methods to test
whether ribbons set the time-course of adaptation to changes in luminance (mean light intensity) and contrast
(variance about the mean) in GCs. Finally, I will identify how ribbons contribute to the formation of GC synaptic
inputs using near-infrared branding and electron microscopy, thus correlating structure to function.
GCs possess receptive fields that integrate information across space and enable the detection of specific
features of the visual scene, such as edges, texture, or motion. Such spatial integration is contingent on tunable
excitatory inputs to GCs, raising the possibility that ribbons are key determinants of the emergence of certain
receptive field properties. To test this, using the Ribeye-ko model, I will measure excitatory synaptic inputs and
spike outputs of ON-sustained and OFF-sustained alpha GCs in response to spatial stimulation paradigms that
probe basic receptive field properties, including center-surround organization, nonlinear spatial integration, and
feature sensitivity (i.e., to stimuli that exhibit texture or motion). I will complement functional studies with
measurements of circuit anatomy, including presynaptic bipolar cell morphology and the organization of synaptic
inputs, to both GC types via two-photon and confocal microscopy. This combinatorial structure-function approach
will allow me to disentangle how ribbons shape overall circuit organizations.

Public health relevance
PROJECT NARRATIVE The overall goal of my project is to determine the functional and structural roles of ribbons at the level of retinal circuit processing, output, and organization. These insights will benefit the pursuit of better diagnoses for retinal diseases and inform the development of therapeutic drugs or devices that restore synaptic transmission to healthier states.